Chronic pain self-management for older adults with cognitive impairment: A randomized pilot trial

Project Summary
Psychosocial interventions for chronic pain are largely untested in the growing segment of the older population
living with mild cognitive impairment or early-stage Alzheimer’s disease and related dementias (MCI/ADRD).
Chronic pain and cognitive impairment each exacerbate symptoms of the other, accelerating functional decline.
While cognitive-behavioral strategies can improve pain-related functioning, standard interventions teaching
these skills may not be effective in older adults with cognitive deficits. This proposed supplement will augment
the work of the parent study, a randomized controlled trial of the STEPS chronic pain self-management
intervention for underserved older adults, by modifying the intervention to be suitable for people living with
MCI/ADRD. The original STEPS, delivered through telephone sessions with a community health worker, is
already designed to address challenges common in low-income urban communities such as low health literacy,
resource needs, and lack of transportation. The new version, called STEPS-CI, will offer simplified chronic pain
education and modified processes for skill-building, and will connect participants to resources for MCI/ADRD
and caregiving. Preparatory work for this supplement included: 1) interviews with experts about the pain
management capabilities and needs of people with MCI/ADRD; and 2) focus groups with people living with
chronic pain and MCI/ADRD. Findings confirmed the need for improved pain management skills in this
population and yielded information about how STEPS could be tailored. The aims of this supplement are as
follows: 1) Based on preliminary findings and in consultation with the newly formed STEPS-CI Advisory
Council, modify the existing STEPS curriculum and program materials; and 2) Conduct a NIH Behavioral
Intervention Stage 1 randomized pilot trial with 50 older adults (with optional care partners) who report chronic
musculoskeletal pain and mild to moderate cognitive impairment, and assess its acceptability and preliminary
effects on primary (pain interference) and secondary (pain intensity and subjective cognitive function)
outcomes. Impact on pain medication use will be an exploratory outcome. Mixed methods will be used to
evaluate key program processes including participant engagement, and to shed light on reasons for observed
outcomes. Pilot study participants will be recruited from the same urban community as the parent trial (Detroit,
MI), leveraging existing mechanisms; and, as an exploratory element, a subset of rural participants in northern
Michigan will also be recruited, given the similarities in access barriers across these two underserved
populations. The National Council of Dementia Minds, an advocacy and support organization led by people
living with dementia, will advise on all study phases and processes through the STEPS-CI Advisory Council.
This pilot study set the stage for a subsequent Stage 2 or 3 trial, if STEPS-CI is shown to be feasible and
demonstrates potential efficacy; otherwise, it will provide valuable information leading to the development of
alternative ways to meet the chronic pain management needs of older adults living with MCI/ADRD.

Public health relevance
Project Narrative An increasing number of Americas are living with both chronic pain and cognitive impairment. Given the heavy burden and risks of medication use in this group, it is crucial that safer, non-drug options for managing pain are developed. We will test a telephone-based program in which community health workers teach pain self- management skills to adults age 60+ with mild cognitive impairment or early-stage dementia, while connecting them to needed resources. Our focus will be on underserved urban and rural older adults. Because this group is at disproportionately high risk for poor functioning due to pain, this research could substantially enhance population health.